Structural profiling of native proteins using fluorosequencing, a single molecule protein sequencing technology

ABSTRACT
Despite the wealth of accurate and high sensitive data from next-gen DNA sequencing technologies,
understanding the impact of the observed genomic mutations or alterations in the transcript (such as from
splicing or transcriptional errors) on the protein structure and function is often unclear. To complicate this
understanding are observations, where small abundant proteoforms can cause toxic intracellular
aggregates. This link between genome/transcriptome to protein structure is unclear, because methods for
characterizing protein structures often involve recombinant protein production and the use of analytical
techniques that perform ensemble analysis. In this proposal, we introduce Fluorescent Protein Painting, a
workflow for obtaining protein’s structural profiles by expanding the Erisyon’s existing fluorosequencing
(single molecule protein sequencing) technology. The steps in workflow are - (a) reversible, covalent
capture of natively folded proteins, (b) fluorescently labeling select surface exposed residues, (c)
releasing, denaturing and digesting the proteins before (d) reacting the internal residues amino acid
residues with second set of fluorophores. Performing fluorosequencing on this population of peptides will
result in generation of protein structural profile or foot-prints on millions of individual peptides. Since the
proteins are directly obtained from their native environment and the method can discriminate different
protein conformations at single molecule sensitivity, we will have a better understanding of the impact of
genomic mutations on the functional state of the biological sample.

Public health relevance
PROJECT NARRATIVE This project aims to advance the understanding of the relationship between mutations observed in DNA and RNA transcripts and the resulting structural heterogeneity of the translated proteins by measuring protein structural profiles in a highly sensitive and quantifiable manner. This proposal will demonstrate workflows and performance necessary for the detection of disease-associated proteoforms through fluorescent protein painting, a process that yields protein conformational profiles for individual protein/peptide molecules using Erisyon’s fluorosequencing technology.